Role of Gs-alpha in regulation of skeletal muscle metabolism

We generated mice with Gs-alpha deficiency in skeletal muscle (MGsKO mice) by repeated matings of muscle heavy chain promoter -cre recombinase transgenic mice with floxed Gs-alpha mice which have loxP recombination sites surrounding Gs-alpha exon 1. Results to date show that MGsKO mice had normal survival and no obvious physical phenotype. MGsKO mice had normal growth and body weight with composition and no changes in food intake and energy expenditure. These results show that loss of Gs-alpha in muscle does not appear to affect whole body energy metabolism on a regular calorie diet. Studies are ongoing to examine whether there are any differences on high fat/high calorie diet. Studies in glucose metabolism (baseline serum chemistries, glucose and insulin tolerance tests, hyperinsulinemic euglycemic clamp studies, and glucose uptake in isolated muscles) show that MGsKO mice are glucose intolerant despite the fact that the mice have normal insulin secretion and hypoglycemic response to administered insulin. In fact studies in isolated muscles show basal glucose uptake to be increased and with no change in glucose uptake in the presence of maximal insulin stimulation, although the increase from baseline with insulin was lower in muscles from MGsKO mice. Studies are ongoing to try to understand the mechanisms underlying the glucose intolerance in MGsKO mice, in particular focusing on whether Gs-alpha stimulates other insulin-independent pathways which lead to glucose uptake. Preliminary results suggest there may be a possible switch in fiber type from type 1 aerobic to type 2 glycolytic, with reduced expression of PGC1-alpha, but further studies are ongoing to further characterize the muscle phenotype and potential effects on exercise endurance.